Molecular Mechanisms of Mutant IDH inhibition and DNA Damage in IDH-mutant Glioma

Project Summary/Abstract:
Gliomas are the most common primary brain tumors in adults, a subset of which have mutations in the metabolic
gene isocitrate dehydrogenase 1 (IDH1). Cancer-associated IDH1 mutants (the most common of which is
IDH1R132H) are neomorphs that produce the oncometabolite 2-hydroxyglutarate [(R)-2HG], which is thought to
contribute to glioma formation. The mutant IDH (mIDH) inhibitor vorasidenib has been recently FDA approved
for the treatment of select IDH-mutant glioma patients and is poised to become standard-of-care. However,
response to mIDH inhibitors is heterogeneous, and our understanding of how these drugs work in glioma has
been severely limited by a lack of faithful animal models that respond to mIDH inhibition. Existing IDH-mutant
glioma mouse models require xenograft transplantation, model high-grade (mIDH inhibitor-resistant) disease,
and/or incorporate mutations that are not frequently observed in lower-grade IDH-mutant gliomas.
In an effort to better understand these unanswered questions regarding mIDH1 biology, I made a
genetically engineered mouse (GEM) model of mIDH1-driven grade 3 astrocytoma that circumvents key
limitations of existing models and responds to mIDH inhibitor treatment. I leveraged this GEM and other models
to show that IDH-mutant gliomas are sensitive to de novo pyrimidine synthesis inhibitors (e.g. dihydroorotate
dehydrogenase (DHODH) inhibitors) due to an increased susceptibility of IDH-mutant cells to replication stress
caused by these drugs. My overall objective is to use my mIDH inhibitor-responsive glioma GEM to address
translationally relevant questions in glioma. In Aim 1, we will use single cell multiomics sequencing technologies
and functional genomic screening to understand mechanisms underlying response to mIDH inhibitors in glioma.
This will include both characterization of transcriptomic and epigenomic changes induced by mIDH inhibition, as
well as unbiased studies to identify transcriptional alterations that are functionally relevant for treatment
response. In Aim 2, we will leverage the immunocompetent and autochthonous status of our GEM to identify
microenvironmental interactions driven by mIDH and transcriptional alterations induced by mIDH inhibition in the
immune microenvironment. In Aim 3, we will assess how mIDH impacts efficacy of DNA damaging therapies
(including standard-of-care radiation and alkylating chemotherapies) and identify mechanisms underlying
sensitivity of IDH-mutant gliomas to DNA damage caused by replication stress (such as DHODH inhibition).
My long-term goal is to understand how mIDH alters glioma biology in order to develop new effective
treatment options for this disease. Results from my Aims will identify biomarkers and mechanisms of response
to mIDH inhibition, nominate combination therapeutic strategies, and reveal mechanistic insights on how mIDH
alters the response to DNA damage. The research proposed here will directly inform how patients with IDH-
mutant glioma are treated in the clinic and also reveal fundamental insights on clinically relevant epigenomic and
microenvironmental reprogramming in IDH-mutant glioma.

Public health relevance
Project Narrative: Gliomas are the most common primary brain tumors in adults, a subset of which harbor mutations in the metabolic gene isocitrate dehydrogenase 1 (IDH1). My project uses a novel genetically engineered mouse model of mutant IDH1-driven astrocytoma and other models to understand how mutant IDH inhibitors exert efficacy in glioma and how mutant IDH1 alters response to DNA damage. These studies will address clinically relevant questions that will inform use of mutant IDH inhibitors in the clinic and nominate combination treatment strategies for patients with IDH-mutant gliomas.